Engaging and affordable home exercise environments for people with disabilities

Abstract
Rates of physical inactivity among people with physical disability (PWD) are significantly higher than in
the general population. PWD have less access to indoor and outdoor physical activity (PA); get less
unstructured PA across the day; and their incidence of chronic health conditions are substantially
higher than in the general population. Thus, there is a strong and growing need to provide
opportunities for PWD to achieve higher levels of regular physical activity.
One potential solution for improved exercise access is home exercise equipment, which if integrated
with engaging, interactive user experiences such as virtual workout environments, group classes, and
social networking, has been proven an effective means for people to participate in a wide range of
personal exercise programs. Exercise equipment supporting these functions is widely available for the
general public. Unfortunately, although a variety of simple, accessible home-based exercise devices
are available, few cost-effective accessible options exist that include these valuable features. In other
words, PWD are often denied the health and wellness opportunities available to the general public in
the form of interactive, engaging exercise.
Vortant Technologies and consortium partner UAB National Center on Health, Physical Activity and
Disability (NCHPAD) intend to address this health-related disparity by creating a universal and
affordable add-on product to upgrade almost any affordable but non-engaging, non-interactive
exercise device. Requiring no special tools or skills to install, this product will enable affordable,
accessible exercise in virtual workout environments, social network connectivity, online group exercise
participation, and will provide quantitative measurement and feedback of workout intensity and effort.
In Phase I, we will expand upon an experimental, patent-pending technology we’ve used to measure
generated power and speed on one example exercise device. The team will further develop the
prototype to upgrade two simple, commonly-available accessible exercise devices. Connecting to an
existing online virtual-workout environment, we will obtain expert therapist feedback, then quantify
functionality, usability, potential affordability, and user preferences with a group of end users at UAB.

Public health relevance
Project Narrative The overarching goal of this Phase I SBIR project is to provide improved exercise opportunities for people with physical disabilities, who currently experience a health-related disparity in terms of access to engaging interactive workout experiences. The resulting product is expected to provide improved and affordable options for the target population to participate in interactive group and individual workout environments.